PHASES Adolescence

PROJECT SUMMARY/ABSTRACT
Pregnant adolescents face synergistic challenges in the context of HIV – heightened risk of maternal infection,
vertical transmission, and maternal and fetal morbidity and mortality compared to adult women living with HIV –
and a largely absent evidence base to inform prevention and treatment strategies. Despite increasing global
attention on HIV among adolescent girls and young women, and strong consensus around the urgent need to
attend to pregnant women in the HIV research agenda, persisting complexities at the intersection of pregnancy
and adolescence have amplified reticence around their inclusion in research. This project seeks to address
these questions and confusions around the ethical permissibility of including pregnant adolescents in research.
To this end, we will build on the substantial contributions our team has made through the R01 NIAID funded
PHASES Project (Pregnancy and HIV/AIDS: Seeking Equitable Study), which developed an Ethics Guidance
to advance the responsible inclusion of adult pregnant women in research to prevent and treat HIV/co-
infections. Building on PHASES findings and core consensus principles in PHASES Ethics Guidance, our goal
is to provide empirically informed guidance for conducting ethically responsible HIV/co-infections research with
pregnant adolescents. To achieve this goal, PHASES Adolescence aims: 1) To identify scientific priorities in,
perceived barriers and enablers to conducting HIV/co-infections prevention and treatment research with
pregnant adolescents through interviews and engagement with stakeholders in the HIV research and advocacy
communities in the US and Southern Africa, including investigators, community advisory board members, and
HIV youth advocates and; and to characterize reasoning around participation in such studies from the
viewpoints of affected adolescents through interviews with pregnant adolescents with or at risk for HIV in the
US and Southern Africa; 2) To identify conditions for responsible HIV/co-infections research with pregnant
adolescents that are responsive to the above priorities, barriers, enablers and viewpoints, through scholarly
ethical and regulatory analysis, and interviews and engagement with stakeholders involved in the ethical and
regulatory review and oversight of research, including ethicists, regulatory and policy experts, and research
ethics committee members; and 3) To develop an adolescence-specific framework for advancing HIV research
in pregnancy, whose utility and acceptability will be vetted by stakeholders in the HIV research and advocacy
communities, and those involved in the ethical and regulatory oversight of research, delineating when and
under what circumstances pregnant adolescents can and should be included in HIV/co-infections research.
Through a rigorous methodological design and the individual and collaborative experience of project
investigators in empirical research, moral analysis, and ethics guidance development, this project aims to
identify a clear path forward for HIV/co-infections research with pregnant adolescents, responsive to ethical
and regulatory concerns that have hampered the evidence base for this critical, neglected group.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because redressing the ethical and regulatory barriers to HIV research with pregnant adolescents is crucial to providing safe and effective treatment for prevention and treatment of HIV and coinfections in adolescents and their offspring. The proposed research is relevant to NIH’s mission to reduce the burdens of illness and disability, through development of clear ethical and regulatory guidance for the conduct of morally complicated HIV research crucial to effective prevention and treatment of HIV in adolescents. Rigorously developed guidance for the conduct of ethically complex research advances the NIH’s goal to promote scientific integrity and social responsibility in the conduct of science.